Neuroimaging Acquisition and Analysis Core

Abstract/Summary: Neuroimaging Acquisition and Analysis Core
The Neuroimaging Acquisition and Analysis Core will be the only core facility dedicated to human brain research
in the state of Nebraska, and the only research core facility of the Cognitive Neuroscience of Development and
Aging (CONDA) Center. This new Core Facility will provide neuroimaging infrastructure and analysis expertise
to four institutions concentrated in a narrow stretch of downtown Omaha: the University of Nebraska Medical
Center (UNMC), the Boys Town National Research Hospital, the University of Nebraska – Omaha, and
Creighton University. The Core will house a collection of state-of-the-art, research-dedicated neuroimaging and
neurostimulation equipment, including a 306-sensor magnetoencephalography (MEG) system, a 3.0T Siemens
Prisma magnet with high-performance gradients and a 64-channel head coil, new electrical and magnetic brain
stimulation equipment, extensive high-performance computing resources, and other tools for advanced cognitive
neuroscience research. The associated equipment and space has underwent significant renovations and
upgrades during the past three years, and already serves a rich community of users comprised of members of
multiple research programs led by established PIs with significant NIH, NSF, and/or foundation awards. The
Core will also play a vital role in all four of the primary COBRE research projects, nurture the emergence of
new research through the Pilot and Mini-Grant programs of the CONDA Center, and host instructional
workshops and other training events. Thus, the Core’s community of users is expected to significantly increase
throughout Phase I. The Core Facility will be directed by Dr. Tony Wilson (UNMC) who is an internationally-
known expert with extensive experience in multimodal imaging, brain stimulation, and advanced data analytics.
In summary, the combination of cognitive neuroscience, advanced neuroimaging, cognitive development, and
brain and cognitive aging will create excellent opportunities for synergistic interactions within the new Core
Facility, and these will spark new research ideas and programs, which will further grow the Core and the
CONDA Center as a whole.